Development and Validation of a High-Fidelity Cardiac Presurgical Planning Platform for Congenital Heart Defects Using 3D Printing Technology

Development and Validation of a High-Fidelity Cardiac Presurgical Planning Platform for
Congenital Heart Defects Using 3D Printing Technology
Background: Congenital heart defects (CHD) affect 1% of infants annually, with greater risk to children
born into low socioeconomic status. Many CHD are associated with high infant mortality rates such as
hypoplastic left heart syndrome (HLHS), a CHD which is fatal unless treated with complex surgical
interventions. By creating Pre-Sure-CHD, a patient-specific preoperative surgical rehearsal and planning
platform, Lazarus 3D will facilitate rehearsal of these complex cases, improving survival rates for infants
born with CHD - particularly those with low socioeconomic status.
Objective: To develop and validate Pre-Sure-CHD, enhancing surgical planning and rehearsal for CHD
by providing surgeons with operable, high-fidelity, patient-specific models.
Methods: The study comprises three specific aims: Aim 1 involves optimizing synthetic materials to
replicate the mechanical properties of cardiac tissues, ensuring realism in the Pre-Sure-CHD models. Aim
2 utilizes proprietary 3D printing technology to create patient-specific prototypes for real CHD cases,
informed by CT and MRI imaging data. Aim 3 assesses the content and construct validity of
Pre-Sure-CHD through surgical planning refinement, recording changes, and collecting metrics for
analysis.
Results: The study aims to achieve milestones, including tuning polymers to mimic cardiac tissue
properties, completing Pre-Sure-CHD prototypes, and obtaining a Likert scale survey score >3.5 and a
10% improvement in surgical metrics.
Conclusion: Successful completion of this project will provide the first cardiothoracic surgical rehearsal
platform for CHD, empowering surgeons to optimize their approaches in a risk-free environment.
Implications: Pre-Sure-CHD holds the potential to revolutionize surgical planning for critical congenital
heart defects, reducing mortality rates associated with these conditions. The project's success will pave the
way for a future Phase II clinical study and collaborations with medical institutions, ultimately
contributing to improved patient outcomes and healthcare advancement.

Public health relevance
This project will systematically assess the transformative impact of the Pre-Sure-CHD platform in improving clinical outcomes for disadvantaged populations, particularly those reliant on public insurance for specialized surgical interventions. Investing in high-quality care for CHD patients, especially patients in lower SES, may decrease the overall cost burden, improve equitable care, and reduce mortality risk for infants born with CHD. Unlike standard 3D printed models, our technology utilizes soft materials with tunable mechanical properties that simulate human tissue, allowing the materials to be dissected, filled with fluid, sutured, and clamped using the same instruments used in real surgery.